Neurophysiological Mechanisms of Recovery of Consciousness

Project Summary
The long-term goal of this research is to elucidate neuronal mechanisms that allow the brain to recover
consciousness and cognition after anesthesia. Some patients recover consciousness prematurely during
surgery. Intraoperative awareness is associated with a significant risk of post-traumatic stress disorder. Others
conversely, do not recover cognitive function long after anesthetics have been discontinued. Delayed recovery
is associated with higher morbidity, longer hospital stays, and increased healthcare costs. While brain activity
monitors have been used for decades to mitigate these peri-anesthetic complications, current monitors of brain
activity are inadequate. Anesthetic awareness cannot be reliably detected or prevented and delayed recovery
of cognition affects a large fraction of patients who undergo anesthesia.
All existing brain activity monitors assume that depth of anesthesia is a continuous one-dimensional
measure closely tied to the anesthetic concentration. In contrast, we show that during recovery of
consciousness after isoflurane thalamocortical system abruptly transitions among a small number of discrete
activity patterns. Transitions among discrete activity patterns persist even when anesthetic concentration is
fixed. While many such transitions occur during recovery, all paths towards wakefulness funnel through a small
subset of discrete activity patterns. Our central hypothesis is that: Transitions among a small number of
discrete activity patterns is a universal feature of recovery from anesthesia and that directed
disturbances of such transitions delay or accelerate recovery. In Aim 1 we will directly record neuronal
activity in the cortex and thalamus during recovery from different anesthetics. We will detect and quantify
transitions among discrete activity patterns using robust statistical methodology developed and validated
recently in our lab. In Aims 2 and 3 we will use a combination of direct recordings of neuronal activity and
precise optogenetic perturbations to determine the role of orexinergic and noradrenergic neuronal pathways in
mediating transitions between different discrete activity patterns. We hypothesize that by manipulating these
arousal pathways will be able to either accelerate or conversely impede recovery. This contribution is
significant because we propose to provide an unprecedented ability to monitor and influence the anesthetic
state. In the short term, this work may lead to the development of robust means of monitoring brain activity
under anesthesia. In the long run, identification of neuronal mechanisms responsible for transitions among
discrete activity patterns may lead to the development of targeted therapies for preventing unintended
awareness and accelerating recovery after anesthesia. The proposed research is innovative because by
focusing on mechanisms underlying abrupt transitions between discrete activity patterns we will identify
previously unknown neuronal processes that sculpt the recovery of consciousness after anesthesia.

Public health relevance
Narrative This project studies mechanisms of recovery of consciousness after anesthesia and is relevant to public health because some patients recover consciousness unexpectedly under anesthesia, while others do not recover cognitive function long after anesthetics have been discontinued. Despite advances in brain monitoring little progress has been made in mitigating these adverse peri-anesthetic events associated with increased morbidity and healthcare costs. Upon completion we will understand how brain activity patterns in the anesthetized brain transform into those observed during wakefulness and how orexinergic and noradrenergic pathways modulate this transformation.